Characterizing the Genomic Basis of Immune-Mediated Resilience Against Tuberculosis in an Admixed Peruvian Population

Project Summary/Abstract
Tuberculosis (TB) remains the global leading cause of death from an infectious agent. Understanding
why some patients present with early symptoms while others develop latent infections is critical for combating
this illness. While environmental factors are known to elevate the risk of early progression, a recent Genome
Wide Association Study revealed that host genetic factors also play a role, with early progression heritability
near 20%. However, TB genetics studies focusing on Europeans, which have dominated the field, suffer from
linkage disequilibrium obscuring causal loci and fail to center on the populations who suffer most from TB. By
contrast, this project will focus on a population from Lima, Peru with high TB burden and admixed ancestry,
which will reveal a broader range of genetic variants and enable more specific mapping of impactful loci. Early
progression risk is likely dictated by the immune response, the primary host-pathogen interface. Therefore,
using transcriptional profiling of monocytes (in bulk) and T cells (as single cells) in combination with genotyping
and environmental covariate data, the objective of this project is to characterize immune phenotypes altered by
genomic background that influence TB progression risk. Specifically, this project will: Aim 1) identify gene
expression immune phenotypes influenced by genetic ancestry, Aim 2) create a novel single-cell analysis
method and use it to identify cell population immune phenotypes influenced by genetic ancestry, and Aim 3)
identify specific genomic variants that alter immune phenotypes and impact TB progression risk. If successful,
this work will elucidate genomic mechanisms influencing TB infection outcomes and deepen our understanding
of immune physiology in a Peruvian population. Knowledge of genetic factors that prevent early progression
can inform the development of therapeutics and vaccines. This work will also produce a powerful method for
association testing in single cell datasets, Covarying Neighborhood Analysis, that can define with great
flexibility and granularity cell populations whose abundance is altered by a clinical phenotype of interest.
Through the fellowship training plan, the applicant will develop: expertise in complex trait genetics,
fluency in the application of and development of bioinformatic methodologies, an understanding of how social
and environmental factors also contribute to infectious disease outcomes, and familiarity with immune
physiology and clinical aspects of infectious disease management. An ideal training environment of close
mentorship by an expert in complex trait genetics of immune-mediated diseases and single-cell methods
development, plus support from a network of advisors with complementary scientific expertise and career
experience in academic medicine, in combination with exposure to relevant coursework and meetings, will
enable the applicant to thrive in this program of study. At the conclusion of this fellowship, the applicant will be
poised to tackle critical problems in computational immune genetics with applications to infectious diseases
and global health, and to bridge the clinical and computational worlds through a career in academic medicine.

Public health relevance
Project Narrative This project will characterize genetic variants that alter immune function and thereby decrease the risk that a tuberculosis-infected patient will progress to active symptoms, which can inform the development of therapeutic and vaccine strategies that augment resilience against progression. Elucidating how immune phenotypes are altered by genetic background will also refine our understanding of basic immune physiology and shed greater functional light on the genetic component of risk for other infectious and inflammatory illnesses. Finally, this work will produce a powerful novel method for association testing in single-cell datasets—Covarying Neighborhood Analysis—that represents a marked advancement in our ability to characterize disease states, therapeutic mechanisms, and basic physiology by defining with unprecedented flexibility and granularity the cell populations whose abundance is altered by any phenotype of interest.